Novel Designs and Methods to Remove Hidden Confounding Bias in Health Sciences

Abstract
A major approach in causal inference literature aimed at mitigating bias due to unmeasured confounding is the so-
called instrumental variable (IV) design which relies on identifying a variable which (i) influences the treatment process,
(ii) has no direct effect on the outcome other than through the treatment, and (iii) is independent of any unmeasured
confounder. IV methods are very well developed and widely used in social and health science, although validity of
IV inferences may not be reliable if any of required assumptions (i)-(iii) is violated. This proposal aims to develop
(a) new IV methods robust to violation of any of (i)-(iii); (b) New negative control methods that can be used to detect
and sometimes to nonparametrically account for unmeasured confounding bias; (c) New bracketing methods for partial
inference about causal effects in comparative interrupted time series studies. The proposed methods will be used to
address current scientific queries in three major substantive public health areas:(1) to understand the health effects of
air pollution; (2) to quantify the causal effects of modifiable risk factors for Alzheimer's disease and related disorders;
(3) To uncover the mechanism by which a randomized package of interventions produced a substantial reduction of
HIV incidence in a recent major cluster randomized trial of treatment as prevention in Botswana, Africa. Our proposal
will provide the best available analytical methods to date to resolve confounding concerns in these high impact public
health applications and more broadly in observational studies in the health sciences.

Public health relevance
Summary This proposal aims to develop new causal inference methods to tame bias due to hidden confounding factors in obser- vational studies as well as in randomized experiments subject to non-adherence. The proposed methods are firmly grounded in modern semiparametric theory which will be used to obtain more robust and efficient inferences about causal effects in a broad range of public health applications including in Epidemiology of Aging, Environmental Health Epidemiology and HIV/AIDS Prevention.